Non-Contact Point of Care Device for Sleep Studies

Project Summary/Abstract
Proposed is an easy-to-use, non-contact, wearable-free, portable method for the diagnosis of obstructive sleep
apnea (OSA) with heart rate, breath rate, and sleep stage monitoring for use in clinical or home settings. Such
a system has the potential to also be used for longitudinal monitoring of sleep during interventions. In this
Phase IIB effort, the team will complete the evaluation and testing required to bring this product to market. The
work also responds to the Notice of Special Interest (NOSI), “Validation of Digital Health and Artificial
Intelligence/Machine Learning Tools for Improved Assessment in Biomedical and Behavioral Research.”
Significance: An estimated 54 million Americans have sleep apnea, and recent epidemiological studies
indicate the prevalence of this disorder is on the rise. OSA is associated with several negative health outcomes
including depression and type 2 diabetes. Currently, polysomnography (PSG) is the gold standard test for
diagnosis of OSA. PSG systems are complex. They typically require a skilled technician for setup and
continuous monitoring to ensure the accuracy of results thereby limiting their use to sleep clinics. However,
recent reviews of access to sleep clinics have found supply of OSA diagnostic services is not always able to
meet demand. Home sleep apnea test (HSAT) systems do exist, however, like current PSG systems, they
employ sensing modalities that suffer from issues of miscalibration or diminished efficacy as the user moves
through the night. Sensors typically used by HSAT systems (nose-worn cannula, EEG, plethysmography belts,
etc.) must be in direct contact with the patient and are wired to a central recorder that the patient must wear.
Patients report that worn/wired sensors are uncomfortable and, in some cases, affect their sleep quality. These
issues present a barrier to effective diagnosis of OSA for many populations including the un/under-insured,
rural populations, individuals with accessibility needs, those with developmental disabilities, and children.
Hypothesis: It is hypothesized that an easy-to-use wearable-free device capable of sensing standard
measures of sleep apnea severity (AHI), heart rate, respiratory rate, and sleep stages will make diagnosis
available to several populations underserved by current PSG and HSAT technology, thereby increasing the
quality of life for those individuals affected by OSA and other conditions. Specific Aims: In the Phase II effort,
the proposed sensing technology was demonstrated to be exceptionally effective. In Phase IIB, the following
aims are proposed: 1) Finalize technology integration, manufacturing, and test product for commercial
readiness, 2) Conduct human subject trial to assess device accuracy compared to gold-standard truth source.

Public health relevance
Project Narrative An estimated 54 million Americans have sleep apnea, a disorder associated with negative health outcomes such as depression and diabetes and the prevalence of this disorder is on the rise. Studies indicate that OSA is markedly underdiagnosed and current diagnostic equipment presents a barrier for many populations. Currently used devices such as polysomnography (PSG) and Home sleep apnea tests (HSAT) are the gold standard test for diagnosis of OSA, but the complexity of setup and monitoring these systems limits their use.